Pathophysiology Core

The primary objective of the Pathology and Imaging Core is to provide accurate phenotypic characterization of
pulmonary vascular remodeling, document activation of complement, assess inflammation, and isolate mRNA
and proteins, in diseased IPAH human lungs and relevant models of PH. To accomplish these goals, we will
perform 8 tasks based on specific methodologies, aimed at integrating high quality tissue processing,
immunohistochemistry, and stereology with high throughput imaging approaches and laser capture
microdissection for all 4 projects in this PPG.
Aim 1: To provide qualitative and quantitative assessment of pulmonary vascular remodeling in lungs
of humans, steers and newborn calves, rats, and mice in Projects 1-4. We propose 4 specific tasks to
support this specific aim, which include: planning of experiments (task 1), collection, processing, and
phenotyping experimental lungs (task 2), morphology and stereology of pulmonary vascular remodeling (task
4), and integration of morphological data with specific project goals and aims (task 8).
Aim 2: To determine expression patterns and abundance of candidate molecules investigated in
experimental lungs. We propose 5 specific tasks to support this specific aim, which include planning of
experiments (task 1), tissue processing (task 2), morphology and stereology (task 3), laser capture
microdissection (LCM; task 7), and integration of morphological data with project goals and aims (task 8).
Aim 3: Specific Aim 3: To obtain high quality mRNA and protein for transcriptomic and proteomic
studies from specific pulmonary vascular structures and lesions from animals manipulated in Projects
1-4. We propose 5 specific tasks to support this specific aim, which include planning of experiments (task 1),
tissue processing (task 2), LCM (task 7), and integration of morphological data with specific project goals and
aims (task 8).
Aim 4: To translate the key expression findings in Specific Aim 2 to human control and PAH lungs. We
propose six specific tasks to support the specific aim, which include planning of experiments (task1), tissue
processing (task 2), human tissue studies (task 3), morphology and stereology (task 4), LCM (task 7), and
integration of morphological data with specific project goals and aims (task 8).
Foremost in accomplishing these goals is the scientific expertise within the leadership of the core. The
Pathology and Imaging Core is led by of Drs. Rubin M. Tuder, an experimental and practicing pulmonary
pathologist with major expertise in pathology and pathobiology of pulmonary hypertension, with the support of
Dr. Raphe Nemenoff, an experienced investigator in the cancer field with expertise in multiprobe immune
imaging targeting the immune system and complement. The novelty of the Pathology and Imaging Core lies
on the unique resources, unmatched expertise, and overall experimental breadth, allowing for the integration
and human translation pertaining to all four projects.

Public health relevance
The Pathology and Imaging Core in this PPG seeks to services in 8 tasks to all Projects. These include tasks involving preparation of lungs to examine the pulmonary vascular disease in the animal models, samples from the Pulmonary Hypertension Breakthrough Initiative, and specialized approaches to isolate pulmonary vascular lesions to perform proteomic and genomic studies. The core uses several state of the art methodologies including a new system to localize up to 9 markers in the same section.